Technology Enabled Strategies to Promote Treatment Adherence in Liver Transplant: The TEST Trial

PROJECT SUMMARY
The prevalence of cirrhosis and end-stage liver disease (ESLD) in the U.S. has nearly doubled over the past two
decades. Liver transplant (LT) is the only life-saving option for ESLD and is projected to increase 23% by 2040.
LT requires considerable healthcare resources, costing the U.S. health system $26.7 billion annually. It is
increasingly performed among older adults; from 2006 to 2018, adults 65 and older were the most rapidly growing
age group on transplant waitlists. By 2019, 70% of LTRs were adults 50 and older. With advances in
immunosuppression (IS) and surgical techniques, average 5-year post-LT survival now exceeds 70%. However,
maintaining optimal, long-term liver graft function and overall health are contingent upon proper adherence to
prescribed treatment. This can be difficult, as liver transplant recipients (LTRs) contend with high regimen
complexity, taking on average 11 new medications that have side effects and require frequent dosage changes.
Many LTRs have lingering cognitive impairments due to pre-transplant hepatic encephalopathy, or other
psychosocial, financial, or cultural factors that all can affect the ability to adhere to treatment. As a result, a third
of LTRs demonstrate inadequate adherence to IS regimens. Poor adherence is a leading cause of liver graft
rejection, liver failure, poorly controlled medical comorbidities and subsequent mortality. Similarly, inadequate
medication knowledge and unintentional misuse are associated with post-transplant hospitalizations. Despite
the negative and costly consequences of inadequate adherence, very few prospective interventions have been
developed and tested to optimize medication-taking behaviors and subsequent outcomes post-LT. However,
there are unique considerations within the context of LT that can be leveraged by interventions: 1) LTRs remain
indefinitely connected to transplant centers for follow-up with a range of available resources; nurse coordinators,
pharmacists, psychological and social services; 2) to be eligible for LT, patients must have involved caregivers
to provide post-LT support (yet no interventions to date have involved caregivers). Our primary aim is to test the
effectiveness of a technology-enabled intervention (TEST trial) to improve treatment adherence and optimize
patient-centered and clinical outcomes among a cohort of 360 de novo LTRs at 3 diverse transplant programs
in Philadelphia, PA, Chicago, IL, and Miami, FL. Our intervention leverages existing transplant center resources,
caregiver support, and widely available patient-centered mobile health tools to remotely monitor LTRs'
adherence behaviors, `phenotype' adherence concerns, and tailor transplant center responses to those
concerns. We additionally plan to assess intervention fidelity, enabling us to evaluate patient, caregiver, provider
and health-system barriers to optimal implementation to enhance scalability. Finally, we will determine the costs
and cost-effectiveness of the intervention from a transplant center and healthcare sector perspective. The TEST
trial will enable the timely identification of the presence and nature of LTR adherence barriers and mobilize
transplant centers and caregivers to deploy tailored solutions by leveraging existing resources to optimize health.

Public health relevance
PROJECT NARRATIVE Liver adults liver process. center among transplantation, the only lifesaving treatment for end-stage liver disease, is increasingly performed for older with multiple comorbidities. Medication adherence is key to maintaining proper function of the transplanted and optimize overall health; however, adhering to post-transplant treatment regimens is a very complex This clinical trial will tudy how readily available technology-enabled tools combined with transplant resources and caregiver support can optimize medication adherence, quality of life, and health outcomes new liver transplant recipients at 3 diverse centers. s